Using catalyst speciation to control reactivity and address longstanding challenges in cross coupling reactions

Project Summary/Abstract
The advent of cross coupling technologies has expanded access to the types of molecules
available for drug screening and accelerated the synthesis of such compounds. Key to these
advances in cross couplings is the discovery and application of privileged ligand scaffolds that
enable high reactivity and broad substrate scope across different reaction types. In this proposal,
we demonstrate that 2-phsophinoimidazole (2-PI) ligands represent a new privileged ligand class
for addressing key challenges in cross coupling chemistry. Our preliminary data demonstrates
that 2-PI ligands can access unique catalytic species by transforming into bidentate P–N
coordination complexes, mixed N-H N-heterocyclic carbene/phosphinite complexes, or bimetallic
complexes. Each of these types of catalysts achieves high reactivity in specific cross coupling
reactions, and our efforts to access and favor specific catalyst structures in catalysis are providing
productive solutions to difficult substrate classes in cross coupling reactions. In particular, the 2-
PI ligands enable efficient catalysis in both Suzuki and Buchwald-Hartwig (BH) aminations with
aryl chloride substrates, including for heterocyclic chlorides common in FDA approved
pharmaceuticals. In aim 1, we will conduct structure activity studies to determine how ligand
structure can influence and favor specific catalyst forms, whether it be the P–N coordination
complex, N-H NHC/phosphinite formation, or bimetallic complex formation. We will then test and
optimize these ligands and catalyst structures in Suzuki and BH amination reactions that employ
challenging sterically hindered and heteroaryl chlorides, sensitive heteroaryl boronic acid
nucleophiles, and sterically hindered amine nucleophiles. In aim 2, we will optimize catalyst
structure with our 2-PI ligands to achieve efficient catalysis with a broad range of heteroaryl
chloride substrates under mild reaction conditions. We will also expand our efforts to optimize
Ullman-type couplings for C-O and C–S bond formation. In Aim 3, we will capitalize on the ability
of our monosubstituted N-H NHC Pd complexes to perform H-bonding accelerated catalysis in
Heck reactions with alkenyl alcohol substrates. We will also optimize reaction conditions for a
tandem Heck/hydroalkoxylation reaction that generates tetrahydrofuran products in a single step.
The studies presented herein are highly amenable to participation by undergraduate researchers
and many of the optimization studies proposed will be led by senior undergraduates. The result
of these studies will be new tools for synthetic and medicinal chemistry that capitalize on the
potential of 2-PI ligands to transform into different metal complexes during catalysis.

Public health relevance
Project Narrative The advent of metal-catalyzed coupling reactions has shaped both the types of molecules that are employed in small molecule drug discovery and how they are synthesized. This proposal outlines the development of a new class of metal catalyst that seeks to address various longstanding challenges in cross coupling reactions. These efforts will provide new tools for medicinal chemists to efficiently access a broader subset of small molecules for drug discovery.